Traveling Waves in Neocortical Circuits: Mechanisms, Computational Roles in Sensory Processing, and Impact on Sensory Perception

PROJECT SUMMARY/ABSTRACT
An important longstanding goal in neuroscience research is to understand how large-scale spatiotemporal
patterns of neural activity emerge in the brain and whether they have a direct role in shaping the brain’s
computational processes and thereby mammalian behavior. Notably, traveling waves of neural activity have
been implicated in sensory, cognitive, and motor behaviors, and this team recently found that intrinsic traveling
waves (iTWs) in visual cortical areas predict the magnitude of evoked spiking activity and visual perceptual
sensitivity in awake, behaving non-human primates. However, it remains unclear whether iTWs reflect an
underlying fundamental mechanism of cortical function or whether they might simply be epiphenomenal.
This project will examine the role of neocortical iTWs in visual perception and is guided by a theoretical model
of iTW activity that makes specific testable and falsifiable predictions about the mechanisms that give rise to the
spatiotemporal features of iTWs and their roles in sensory behavior. The model is based on a network of spiking
neurons and predicts that iTWs emerge from the anatomical organization of horizontal cortical fibers and result
in shifts in the balance of excitatory (E) and inhibitory (I) population activity that travel as waves, The model
further predicts that iTWs are retinotopically coordinated across visual cortical areas, and that this coordination
is the mechanism by which iTWs improve perception. However, these predictions could be wrong. Empirical
tests of the model’s predictions will require activity measurements from specific neuron-types, across wide fields-
of-view, and with excellent spatial and temporal resolution in awake behaving animals.
To perform such measurements, the team recently invented several new technologies: (1) genetically encoded
fluorescent voltage indicators (GEVIs) that they will target to specific E or I neural populations; (2) a custom-built
dual-color fluorescence mesoscope to track the subthreshold population voltage dynamics of 2 neuron-types at
once, across a 8-mm field-of-view spanning multiple cortical areas in marmoset and mouse cortex; (3)
transparent electrode arrays that allow measurements of LFPs to be performed across the cortex concurrently
with voltage imaging studies of E and I population activity; (4) transparent laminar electrode arrays to measure
the spiking activity of cells across the different cortical layers. By combining the use of these four innovations in
marmosets and mice performing a visual detection task, the team will test the predictions of the theoretical model
and learn how different cortical neuron-types impact iTW dynamics and perceptual sensitivity.
Aim 1 tests the hypothesis that E/I population activity travels as iTWs in mice and marmosets. Aim 2 tests the
prediction that iTWs are coordinated retinotopically across cortical areas, and that this coordination enhances
perceptual sensitivity. Aim 3 will account mechanistically for the results of Aims 1 and 2 in a theoretically
grounded spiking network model. Overall, by using innovative new technologies this interdisciplinary team will
provide key insights into longstanding conceptual issues of profound importance to brain research.

Public health relevance
PROJECT NARRATIVE In recent years, neuroscientists have increasingly come to appreciate the importance of understanding how the spatiotemporal organization of large-scale neural activity patterns influences perception, cognition, and motor control. Our project focuses on intrinsic traveling voltage waves (iTWs) in the mouse and marmoset sensory neocortex, how these waves may influence perceptual sensitivity and mammalian visual behavior, and the contributions of specific cortical neuron-types to these phenomena. To examine these issues, our research team comprises experts in visual neurophysiology and behavior, inventors of novel optical voltage-imaging and electrophysiological recording techniques, data scientists innovating advanced statistical analysis methods, and computational neuroscientists whose models of iTWs provide specific predictions that we will test empirically in mice and marmosets performing a visual detection task.